MITOCHONDRIAL MECHANISMS IN OPTIC NEUROPATHY

DESCRIPTION (provided by applicant): Autosomal dominant optic atrophy (ADOA) and Leber's hereditary optic neuropathy (LHON) are the two most common inherited optic neuropathies, they are each caused by deficiencies of mitochondrial function, and result in death of Retinal Ganglion Cells (RGCs), causing blindness. Thus RGCs are especially sensitive to deficits of mitochondrial function for an unknown reason. Our overarching goal is to elucidate the mito-pathophysiological mechanism of these mitochondrial optic neuropathies, and develop therapeutic leads. Currently no curative therapy exists for ADOA and LHON for multiple reasons. The reasons include the lack of an RGC-specific pathophysiological mechanism for the disease, the lack of animal models, and the lack of a high-throughput screening assay for drugs that improve mitochondrial function. We have addressed each of these issues in the former grant period and request support to continue our studies. For example, we have demonstrated that mitochondrial complex 1 inhibition signals cell death through the activation of a 'mitoinjury response': mito comp1AE ROSAEERAE ATF4AE targetsAE death, and this mitoinjury response and cell death can be blocked by blocked by interruption of the signal at ER or ATF4. We observe that persistent activation of this response by mitochondrial oxidative stress results in cellular dysfunction and death, and that inhibition of this response rescues cells from death. In animal models of the diseases, LHON: the ndufs4 mouse, and ADOA: the opa1 mouse, there is neurodegeneration of RGCs, and dendropathy of RGCs, respectively, resulting in defects of visual function. Thus, our plan has three overarching goals. First, to elucidate the pathophysiological mechanism of RGC death in two recently-derived animal models of mitochondrial disease. Secondly, we will investigate specific aspects of signaling in cellular models of the diseases. Thirdly, we will screen libraries to isolate drugs that rescue mitochondrial function and block ROS and cell death, and test them in the animal models, in preparation for clinical trials in humans.

Public health relevance
LHON and ADOA are the two most common inherited optic neuropathies. Our project is to validate a specific pathophysiological mechanism we have developed from our previous award in two animal models of LHON and ADOA, the ndufs4 and opa1 mouse. In addition we carry out a 'repurposing' drug screening isolate drugs that increase mitochondrial function, and will test these in cell and animal models of LHON and ADOA.